Exploring the precise role of heparanase via small molecule probes

Abstract
The extracellular matrix (ECM) is an essential component of the microenvironment of cells and is known to
provide mechanical supports for organs and tissues, as well as loci for cell adhesion, interaction, and signaling
to regulate various cell functions. Heparan sulfate proteoglycans (HSPGs), major components in the ECM of all
tissue types, maintain the structural integrity of ECM and regulate cellular signaling via binding with ECM
components and protein ligands such as growth factors and chemokines. Heparanase, the only known enzyme
that can cleave the heparan sulfate (HS) side chains of HSPGs and a key enzyme for ECM remodeling,
regulates many cellular processes including ECM remodeling and homeostasis of cell-associated HS, and it
controls the bioavailability and activity of molecules attached to HS. The importance of heparanase activity in
various pathological conditions such as cancer, angiogenesis, and inflammation has been well demonstrated,
however, a detailed mechanistic study of heparanase function and the precise mode of heparanase action in
ECM remodeling remain elusive. Molecular probes that can dissect the different functions of heparanase can
explore its precise role in ECM remodeling, however, prior to our work, there were no suitable tools for this
type of investigation. Our overall research program has been built on the development of novel heparanase
probes that have defined structures, and “in situ” labeling chemistry that can facilitate real-time detection of
heparanase activity both in vitro and in vivo. With the support of MIRA-ESI, my lab has successfully developed
efficient chemical strategies to yield novel small molecule probes to detect heparanase activity, and “in situ”
labeling chemistry suitable for carbohydrate processing enzymes. In the proposed MIRA application and the
long term, we will develop a library of novel heparanase probes with varying glycan substrates and use these
structurally defined molecules to study the precise function of heparanase using in vitro and in vivo models
involving ECM remodeling.

Public health relevance
Project Narrative Despite the significance of heparanase in various physiopathological conditions, the precise mode of action of heparanase is not completely elucidated. We aim to create a series of small-molecule probes with specific glycan structures to investigate heparanase activity in real-time, both in vitro and in vivo. These novel tools will provide fresh insights into the precise role of heparanase in the extracellular matrix remodeling process.